INTERDISCIPLINARY BIOMEDICAL RESEARCH PROGRAM

The goal of the San Jose State University MBRS-SCORE Program is to carry out a program of meaningful biomedically-relevant research in a manner that contributes new knowledge, maximizes the development of research skills and scholarship of its participants, and enhances the overall research and scholarly capacity of the university. Since its inception20 years ago, the San Jose State University MBRS Program has been interdisciplinary and integrated in nature. Thus, the skills and the interests of the individuals involved have been complimentary and several of its members have developed collaborative arrangements with others in the group. We have documented the success of this approach elsewhere in this program is designed to accelerate the trends of achievement by including project proposals from six members of the Department of Biological Sciences, four members of the Chemistry Department and three members of the Department of Psychology. Several of those who are involved in this proposal are beginning their research careers and will play important roles in shaping the future of research at scholarship at San Jose State University.